Nutrition, late fetal and neonatal mortality in the African context

Project Summary
Stillbirths and neonatal deaths are two adverse birth outcomes of critical global health relevance. In 2021, an
estimated 1.9 million babies were stillborn, and 2.3 million liveborn babies died before reaching 28 days of age.
Sub-Saharan Africa (SSA) stands out globally as the world region having the largest number of stillbirths and
neonatal deaths (respectively 847,000 and 1,067,000 in 2021). These large numbers not only reflect large
population sizes, but also high levels of stillbirth and neonatal mortality in the SSA region. Moreover, not only
are neonatal mortality rates high in countries of the SSA region relative to other world regions, but in many
SSA countries, they are high relative to the country’s own levels of postneonatal mortality. This indicates the
existence in many SSA populations of a distorted age pattern of mortality at early ages with excess mortality at
neonatal ages, impeding their ability to meet Sustainable Development Goals targets. In spite of the
significance of these patterns, measurement and understanding of stillbirth rates and neonatal mortality in
SSA countries are hindered by major gaps in data availability and quality. Undercount of stillbirths and
neonatal deaths as well as misclassification of neonatal deaths vs. stillbirths in existing, mostly retrospective
sources remain major concerns. Issues with availability and quality of information on preterm, low birthweight
and small for gestational age – three major risk factors that can play a large role in both levels and age patterns
of early-age mortality – are additional gaps that further impede proper monitoring of patterns of mortality
during the late fetal and neonatal periods in the SSA region. The goal of this project is to improve our
understanding of why many SSA populations stand out globally in terms of both their levels and age patterns of
mortality during the late fetal and neonatal periods by collecting new prospective data in three surveillance
sites located in three different SSA countries (Ethiopia, Gambia and Guinea-Bissau), covering a variety of
contexts. While the focus of this project is on three SSA populations located in Ethiopia, Gambia and Guinea-
Bissau, results will have methodological and substantive implications for other low-income countries, including
other SSA countries, which are characterized by a high burden of stillbirths and neonatal mortality as well as
large data gaps in their stillbirth and neonatal mortality information.

Public health relevance
Public Health Relevance Information on how the risk of death varies with age during the late fetal and neonatal periods in resource-poor settings such as the sub-Saharan African countries of focus in this study represents critical evidence for health policy. This information, together with risk factors such as preterm, low birthweight and small for gestational age, will help understand which newborns are most at risk of death, guide policy action and improve progress for children. The present study will make important substantive and methodological contributions to understanding the dynamics of late fetal and neonatal mortality in the sub-Saharan Africa context, with implications for other low-income countries where stillbirth and neonatal mortality rates remain high.